CCOP--NSABP RESEARCH BASE BIOSTASTICS CENTER

The primary aim of this application is to continue the active role that the National Surgical Adjuvant Breast and Bowel Project has had as an NCI- designated research base for the CCOP. Specifically, the NSABP will: provide breast and colorectal clinical treatment protocols and cancer control research protocols for participating CCOP physicians; provide support services and educational programs for CCOP-related staff; monitor CCOP performance through ongoing quality assurance programs; and continue the successful integration of CCOP investigators into the overall functioning of the NSABP. According to the applicant, as a CCOP research base since 1983, the NSABP has more CCOP affiliations than any other clinical cooperative group. As a result of their collaborations, the NSABP has accounted for approximately 20% of all CCOP clinical trial treatment accruals and for approximately 15% of all subjects entered on cancer control studies over the past three years. Within the NSABP, CCOPs are currently contributing 30% of all adjuvant study accrual. The applicant anticipates that by maintaining this expanded involvement of CCOP physician in NSABP studies; 1) the benefits of clinical trial participation will continue to be widely available in the community setting, where over 80%of all cancer patients are treated; 2) answers to the therapeutic questions posed in study protocols will be available more quickly; and 3) a wider segment of the community will be available for research and measurement of advances in cancer control.